The VITamin D and OmegA-3 TriaL (VITAL): Post-Intervention Follow-Up

Black women or socioeconomically disadvantaged women diagnosed with breast cancer are
critical U3 (understudied, underrepresented, and underreported) populations of public health
importance that are likely to have clinically relevant comorbidities, such as depression. To
evaluate the hypothesis that women diagnosed with breast cancer experience changes in
depression symptoms, we will leverage the Vitamin D and Omega-3 Trial (VITAL; National
Center for Complementary and Integrative Health (NCCIH): 9R01AT011729; PI: Manson) and
VITAL Depression Endpoint Prevention (VITAL-DEP) data. We will evaluate change in
depressive multimorbidity and Patient Health Questionnaire-8 (PHQ-8) data in 234 women
before and after their breast cancer diagnosis compared to women without incident invasive
cancer in VITAL. These secondary analyses have the potential to lead to greater awareness and
expanded screening for depression in the cancer treatment and survivorship period, leading to
critically needed patient navigation and support services addressing the mental health needs of
U3 women.

Public health relevance
Black women diagnosed with breast cancer are critical U3 (understudied, underrepresented, and underreported) populations of public health importance that are likely to have multimorbidity. We will evaluate change in depressive multimorbidity and Patient Health Questionnaire-8 (PHQ-8) data in 234 women before and after their breast cancer diagnosis compared to women without incident invasive cancer in the Vitamin D and Omega-3 Trial (VITAL). The results of these secondary analyses will address Objective 1.2 in the 2019-2023 Trans-NIH Strategic Plan for Women’s Health Research and the Cancer Moonshot 2.0 to improve the experience of people living with and surviving cancer.